Subject Management and Biobanking

PROJECT SUMMARY CORE B
The Center for Adolescent Rhythms, Reward, and Sleep (CARRS) Phenotyping and Biobanking Core (Core
B) supports the research projects through the acquisition of research subjects with specific phenotypic
characteristics required by the human and animal projects. The central hypothesis of CARRS is that changes in
sleep and circadian rhythms associated with adolescent development impact cortico-limbic functions critical to
substance use risk (e.g., reward and cognitive control). The coordinated and deliberate procedures for assuring
analogous phenotypic characteristics in humans and animals provide the foundation for this translational
scientific program. For human studies (Project 1), Core B will conduct systematic recruitment and screening of
adolescents ages 13 through 18 years old to provide participants stratified by cannabis use risk and will conduct
biannual follow-up assessments in all human participants from CARRS-1 (years 01-05 in P1/P2) and all newly
enrolled CARRS-2 human participants (years 06-10 in P1). For rodent studies, Core B will continue a breeding
and circadian rhythm and sleep manipulation pipeline to provide the animals required for Projects 3, 4 and 5.
Core B will also provide biobanking services, including the collection, management, and banking of
biospecimens from adolescent humans and adolescent HS rats to measure molecular rhythm phenotypes and
to provide a high-quality repository for future mechanistic studies. Core B contributes to this innovative
translational research program by collaboratively developing and implementing plans for assuring analogous
phenotypes for CARRS human adolescent and adolescent rodent model studies.